Integrated Early Intervention for Alcohol Use Disorder and Posttraumatic Stress Disorder Following Sexual Assault- K23 - Supplement

ABSTRACT
The overall objective of the proposed Mentored Patient-Oriented Research Career Development Award (K23) is
to support Dr. Christine Hahn in acquiring the skills necessary to become an independent investigator with a
program of research focused on the development of interventions for alcohol use disorder (AUD) and comorbid
mental health conditions, in particular posttraumatic stress disorder (PTSD). AUD and PTSD frequently co-occur
among people who experience traumatic life events, such as sexual assault. However, there is a lack of
established evidence-based interventions to reduce AUD and PTSD among recent victims. The current study
directly addresses this clinical gap by testing the novel integration of two, evidence-based, cognitive-behavioral
interventions for AUD and PTSD to be delivered in five sessions beginning in the six weeks following sexual
assault. Dr. Hahn adapted the intervention using an iterative process informed by expert feedback (Phase 1)
and is conducting an open label trial (n = 10) to finalize the treatment protocol (Phase 2). In Phase 3, the
treatment protocol will be tested in a pilot randomized controlled trial (RCT) among recent sexual assault victims
(n = 54) to evaluate feasibility and preliminary efficacy in reducing AUD severity and PTSD symptoms. Ecological
momentary assessments (EMA) will be used to assess alcohol use, craving, and affect during the five-week
treatment phase. Administrative support is needed to ensure the pilot RCT is successfully implemented during
the critical life events of childbirth and subsequent primary caretaking responsibilities. Administrative support will
be used to hire a research assistant to complete essential study tasks including participant recruitment,
administering study assessments, providing participant renumeration, and monitoring ecological momentary
assessment data collection. Acquiring a research assistant will result in more successful recruitment, enrollment,
and participant completion of the study. The supplement will ensure the PI continues to focus on receiving
dedicated mentorship and achieves the following career goals: (1) Gain new knowledge in AUD mechanisms
and interventions; (2) Develop skills in designing and implementing clinical trials for AUD and co-occurring PTSD;
(3) Increase statistical skills with multilevel and longitudinal data analyses; (4) Enhance understanding of
research ethics; and (5) Continue professional development through manuscript writing, professional
presentations, and grant writing. Dr. Hahn is completing K23 activities at the Medical University of South
Carolina, which has a strong track record of commitment to the advancement of early-stage AUD investigators.
Administrative support to complete the K23 activities will ultimately prepare Dr. Hahn to lead a program of
rigorously-designed AUD treatment outcome research.

Public health relevance
PROJECT NARRATIVE The current project aims to develop and evaluate an early, brief, integrated intervention to reduce alcohol use disorder (AUD) and posttraumatic stress disorder (PTSD) symptoms after recent sexual assault. AUD and PTSD are two common intersecting health outcomes that contribute to public health care costs. Results from the proposed research will set the stage for a more rigorous randomized controlled trial of the brief intervention for AUD and PTSD, which has the potential for high impact and to be highly scalable.